Radioluminescence dosimetry solution for precision radiation therapy

Radioluminescence dosimetry solution for precision radiation therapy
Project summary
Radiation therapy (RT) is an important modality for cancer management. Clinically, over 60% of all
cancer patients in the US receive RT each year as therapy or for palliation, or as an adjunct to surgery or
chemotherapy. There is also increased evidence that RT in combination with checkpoint immunotherapy
is highly effective in treating a subset of cancer patients. In practice, however, because of the invisible
nature of X-ray and its complex interaction process with media, how to ensure the geometric and
dosimetric accuracy of incident RT beams presents a significant challenge in precision RT and critically
determines the success of patient treatment. In this project, we form an academic-industrial collaboration
to investigate and create a clinically translatable solution for substantially improved RT quality assurance
(QA) using a radioluminescence imaging technique recently developed at Stanford. On the basis of our
promising preliminary work, we hypothesize that the accuracy, efficacy and cost of geometric and
dosimetric QA measurements of linear accelerators (LINACs) can be substantially improved with the use
of radioluminecsnce imaging strategy. With the proposed research, we anticipate that submillimeter
accuracy in geometric measurements and better than 3% accuracy in dosimetric measurements will be
readily achievable with orders of magnitude less time and effort as compared to current practice, removing
a major workflow bottleneck in clinical QA and reducing potential radiation treatment errors. This
research presents a first-of-its-kind machine QA strategy capable of instantaneously measuring complex
geometric and dosimetric characteristics of LINACs. If successful, the partnership will lead to a much
safer and more efficient radiation oncology practice, and enable patients to truly benefit from modern RT
modalities such as VMAT and IMRT and SBRT. In addition, the proposed strategy is quite general and
the system developed here will also be valuable for QA applications of other treatment modalities, such
as proton therapy and high-dose rate (HDR) brachytherapy.

Public health relevance
Radioluminescence dosimetry solution for precision radiation therapy Project narrative This academic-industrial collaboration will investigate and create a clinically translatable solution for more accurate and reliable quality assurance (QA) measurements of linear accelerators in radiation therapy by developing a novel radioluminescence imaging technique. If successful, the research will substantially improve the safety, quality and efficiency of radiation oncology practice, and enable patients to truly benefit from modern radiation therapy modalities such as VMAT and IMRT and SBRT.